NYR-Diabetes Research Center (NYR-DRC)

Abstract
The Human Therapeutic Organoid Core (HTOC) facility was founded in September 2022 at Weill Cornell
Medicine to provide a central facility driving human organoid technology development and application. After
spending the first year obtaining operating approvals, developing protocols and standard operating procedures,
and obtaining and banking cells, it was immediately recognized that the HTOC can have a broader mission to
serve regional diabetes and metabolic research through the New York metropolitan area. As such, in the fall of
2023 it was agreed that the HTOC would become an important component of the NYR-DRC, that will allow for
an increase in the efficiency and cost effectiveness in service of all regional diabetes research investigators.
The mission of HTOC is to accelerate organoid-based scientific discovery and therapeutic development. To
accomplish this, the HTOC supports cutting-edge basic, translational, and clinical research investigators at
Weill Cornell Medicine and the broader community of NYR-DRC investigators. Organoids hold great promise
for the basic cellular and molecular understanding of metabolic networks and intercellular cross
communication, and for translational efforts that may revolutionize healthcare with multimodal potential for new
drug development, precision medicine, regenerative medicine, and transplantation-based therapies for end-
stage diseases. The biological complexity of organoids is a strength, but quality-controlled production of
organoids, accumulation of relevant expertise in-house, and the cost of manufacturing represents significant
challenges for many laboratories to deploy this technology effectively. HTOC aids in overcoming these
challenges and helps research groups rapidly and seamlessly incorporate the latest organoid technologies into
their ongoing work. The core grows organoids of different cell lineages (pancreatic islets, colon, small intestine
and is currently developing hepatocyte organoids) derived from NIH approved human pluripotent stem cell
(hPSC) lines and biopsy/autopsy tissues and provides the organoids as a fee-for-service. The central facility
overcomes the technical challenges of quality control and reproducibility often found when using organoid
technologies. HTOC will provide an opportunity for NYR-DRC laboratories to offset the high costs of
establishing and sustaining this technology, in addition to the unnecessary duplication of resources. The
proposed HTOC facility will accelerate NYR-DRC’s scientific discoveries using hESC-derived and human
tissue-derived organoid models.

Public health relevance
Relevance The Human Therapeutic Organoid Core provides a cost-effective and high-quality resources that facilitates scientific progress through the generation of biologically functional three-dimensional human organoid cell culture systems for basic and pre-clinical studies.